Early Life Adversity and Affective Dynamics: Integrating EMA And Multimodal MRI To Understand Depression Risk

Project Summary/Abstract:
Early life adversity (e.g., maltreatment; exposure to neighborhood violence) significantly increases depression;
this includes episodes, reoccurrence, and symptoms of depression, as well as reducing efficacy of common
treatments for this disorder. Despite being well-studied and well-replicated, the exact mechanisms mediating
these linkages remain unclear. Here, we will examine if behavioral and neural variations related to positive
affect are impacted by early life adversity and contribute to depressive symptoms. Specifically, the proposed
project will (1) determine if there’s a reduction in the behavioral persistence or intensity of positive affect for
youth exposed to adversity, (2) probe if individual differences in neural reactivity (persistence and intensity)
relate to adversity and positive affect, and (3) interrogate if sex moderates neural and behavioral dynamics
related to positive affect. To probe these questions, we will use: a) well-validated measures of early life
adversity and depression; b) an affective film viewing paradigm, c) ecological momentary assessments (EMA)
to measure real-world emotional responses and d) a multimodal MRI session. Particularly unique, EMA will
include two, intermixed experience-sampling phases: baseline and game. The game phase will allow our team
to experimentally manipulate positive affect in our participants, measuring affective reactivity and the duration
of real-world affect in response to the game. We hypothesize that overall levels of positive affect, as well as the
persistence of positive affect after an experimental manipulation, will be diminished in youth exposed to high
levels of adversity. Neurobiologically, positive affect is related to the integrity of the corticostriatal circuit, as the
function and connectivity of the ventral striatum (VS) and portions of the prefrontal cortex (PFC) are critical to
appropriate responses to rewarding and motivationally salient stimuli in one’s environment. We will deploy
cutting-edge neuroimaging analytics to examine the reactivity dynamics of multiple critical corticostriatal hubs
(e.g., VS; portions of PFC), with a specific interest in the amplitude and width of neural responsivity (to
understand persistence and intensity of neural responses). We predict that childhood adversity will be
associated with an inability to sustain corticostriatal reactivity. Examined collectively, this novel project affords
an opportunity to identify critical behavioral and neural mechanisms connected to adversity-related depression
risk. With an inability to sustain positive affect being a hallmark of depression, these results would suggest new
mechanisms about how adversity may contribute to mood dysregulation. Sustained progress on this issue
could produce insights that practitioners could use in reducing the negative mental health consequences of
early life adversity.

Public health relevance
Project Narrative Early life adversity has been linked to greater depression, but the mechanisms mediating these linkages are still unclear. Here, we explore an understudied, potential pathway-- brain and behavioral responses to positive affect. Understanding such connections could aid in improving mental health in those exposed to adversity.